Islet-specific CD8 T cells in the pathogenesis of type 1 diabetes

Project Summary
Type 1 diabetes (T1D) is a chronic autoimmune disease characterized by the destruction of insulin-producing
beta cells in the pancreas. CD8 T cells play a crucial role in this process, but the specific antigens they target
and the molecular mechanisms driving their pathogenicity remain poorly understood. This knowledge gap
hinders the development of targeted therapies to prevent or reverse T1D progression. Our proposed research
aims to address this critical need by comprehensively investigating CD8 T cell antigen specificity and molecular
signatures across different stages of T1D development. This project will employ innovative high-throughput
screening methods, single-cell RNA sequencing, and advanced computational analyses to achieve three main
objectives: (1) Identify novel epitopes recognized by islet-infiltrating CD8 T cells from T1D organ donors, focusing
on both native proteins and potential neoepitopes, such as hybrid insulin peptides and RNA splice variants,
preferentially expressed by ‘stressed’ islets. (2) Determine the molecular phenotypes specific to islet-reactive
CD8 T cells within pancreatic lymph nodes of individuals at various stages of T1D development, comparing them
to virus-specific T cells to elucidate unique features associated with autoimmunity. (3) Characterize the molecular
signatures of preproinsulin-specific CD8 T cells in peripheral blood across different stages of T1D development,
from prediabetic (islet autoantibody-positive) individuals to those with new-onset T1D. By integrating data from
these complementary approaches, we expect to gain unprecedented insights into the antigen specificity and
functional states of autoreactive CD8 T cells throughout T1D progression. This research has the potential to
revolutionize our understanding of T1D pathogenesis and enable the development of novel biomarkers for early
detection and monitoring of disease progression. Moreover, the identification of key molecular pathways involved
in T cell activation and beta cell destruction may guide the design of more effective, targeted immunotherapies
for T1D prevention and treatment. Ultimately, this project aims to improve the lives of individuals at risk for or
living with T1D by identifying novel T cell epitopes and molecular signatures specific to disease progression.
These findings will pave the way for developing more accurate predictive biomarkers and antigen-specific
immunotherapies, bringing us closer to the goals of early intervention, disease prevention, and potential reversal
of beta cell destruction in T1D.

Public health relevance
Project Narrative Type 1 diabetes occurs due to autoimmune destruction of insulin-secreting beta cells in the pancreas. Identifying target molecules (i.e. antigens) for T-immune cells is important to develop immunotherapy to halt autoimmune attack against beta cells and ultimately prevent and cure type 1 diabetes. In this project, we will determine antigen specificity and phenotypes of CD8 T-immune cells that are crucial in the pathogenesis of type 1 diabetes.